Defining the cell-autonomous role of caveolin-1 in adult hippocampal neurogenesis in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT:
Over 95% of Alzheimer’s Disease (AD) cases worldwide are sporadic, late onset (LOAD) affecting individuals
age 65 years or older. One of the earliest clinical symptoms of AD is impairment in hippocampus-dependent
memory. Throughout life, the hippocampus notably maintains a pool of neural stem and progenitor cells
(NSCs/NPCs) that differentiate into granule cell neurons (GCs) through the process of adult hippocampal
neurogenesis (AHN). AHN is imperative for hippocampal plasticity and memory function as newly born GCs are
recruited in memory engram cells. It is well-known that AHN is impaired in mouse models of AD and
augmentation of AHN in AD mice rescues hippocampus-dependent memory function. However, the mechanisms
underlying compromise in AHN in AD are not clear. Caveolin-1 (Cav-1) is a scaffolding protein abundant in
endothelial caveolae. We and others have shown that reductions in Cav-1 expression in the hippocampus induce
AD-like pathology and memory deficits. Preliminary studies in our lab show that AHN is impaired in a global Cav-
1 knockout mouse and restoration of endothelial Cav-1 in this model does not restore the pool of NSCs
suggesting a novel autonomous role of Cav-1 in AHN. Importantly, my preliminary results show that cell-
autonomous deletion of Cav-1 in hippocampal NSCs/NPCs compromises expression of critical AD-linked
proteins including amyloid precursor protein, β-secretase (BACE-1) and phosphatidylinositol binding clathrin
assembly protein (PICALM), a genetic risk factor of late onset AD. This project will examine the hypothesis that
Cav-1 regulates AHN in a cell-autonomous manner and that altered expression of neurogenic Cav-1 in
AD may underlie deficits in neurogenesis. Utilizing a newly generated mouse model harboring conditional
deletion of Cav-1 in NSCs (NestinCreERT2;Cav- 1lox/lox), studies in Aim 1 will establish the cell-autonomous role
of Cav-1 in AHN. Aim 2 will elucidated the fate of Cav-1 in hippocampal NSCs/NPCs derived from two AD
models, APPswePS1ΔE9 and APPKINL-G-F/NL-G-F, and determine how Cav-1 regulates expression and membrane
lipid raft localization of AD-linked protein and phenotype of hippocampal NSCs/NPCs in AD. Taken together, this
project will provide imperative insight into Cav-1 as an novel and essential regulator of AHN and establish
whether alterations in Cav-1 contribute to impairments in hippocampal NSCs/NPCs function in AD. This project
implies that restoring Cav-1 level in AHN may help attenuate memory deficits in AD.

Public health relevance
PROJECT NARRATIVE: The cause of memory loss in Alzheimer’s Disease remains largely unknown. It is essential to understand the molecular mechanisms underlying hippocampus- dependent learning and memory, the earliest and most affected in the disease. This project will define the functional role of Caveolin-1 in adult hippocampal neurogenesis and establish Caveolin-1 as novel contributor to hippocampus- dependent memory impairments in Alzheimer’s Disease.